Identifying Community-Informed DoxyPEP Implementation Strategies to Guide Equitable Delivery of Syphilis Prevention

Project Summary/Abstract
In this R21 proposal, we will use implementation science approaches to study delivery of equitable syphilis
prevention, doxycycline post-exposure prophylaxis (doxyPEP), in a clinic-based setting. Innovative strategies for
syphilis prevention are needed to address the growing national epidemic, with disproportionate burden of disease
among Black and Hispanic/Latinx sexual and gender minority persons (SGM) who have sex with men. In
Chicago specifically, syphilis rates have been rising steadily, syndemic with HIV transmission. Existing public
health responses – contact tracing, testing, and treatment – have not stemmed these rising rates. Recent data
show that doxycycline, taken after sexual activity, is very effective at prevention of syphilis for those who may be
exposed. As an emerging evidence-based intervention, key implementation information is needed to ensure
equitable delivery of doxyPEP to maximize impact on the syphilis epidemic. As has been recognized with other
biomedical prevention tools such as HIV pre-exposure prophylaxis, early identification of barriers to delivery is
imperative. The proposed study will address gaps in doxyPEP delivery using implementation frameworks in
partnership with an SGM-focused health system in Chicago, Illinois, to meet the following aims: 1) Assess
determinants of doxyPEP use at the patient, provider and health system levels; 2) Identify and select community-
informed implementation strategies to support doxyPEP use among populations most affected by the syphilis
epidemic; and 3) Develop and evaluate acceptability, feasibility, and appropriateness of a doxyPEP
implementation strategy package among patients, providers, and health systems stakeholders. Our mixed
methods approach will be rooted in the Consolidated Framework for Implementation Research (CFIR) and the
Capability, Opportunity, and Motivation Model of Behavior (COM-B), incorporating qualitative methods and
conjoint analysis approaches, to identify important determinants of doxyPEP service delivery. The proposed
research will result in implementation strategies to guide equitable use of doxycycline post-exposure prophylaxis
among populations most impacted by syphilis.

Public health relevance
Project Narrative Rates of syphilis infection have risen steeply, disproportionately impacting populations of color and sexual and gender minority persons, particularly men and transgender women who have sex with men. A new method for preventing syphilis, consisting of doxycycline post-exposure prophylaxis, is showing promise in research studies. This study seeks to understand how to support adoption of doxycycline post-exposure prophylaxis in populations most impacted by syphilis in the United States.